Treatment of Vocal Fold Paralysis with Muscle Progenitor Cells

ABSTRACT
Vocal fold paralysis (VFP) occurs when the recurrent laryngeal nerve (RLN) is injured, most frequently during
thyroid surgery. This occurs in over 100,000 patients on one side and over 20,000 patients on both sides
annually in the US. Unilateral paralysis of the laryngeal muscles causes hoarseness of voice and aspiration with
swallowing; bilateral paralysis causes airway obstruction, with about 50% of patients needing a tracheotomy
for adequate breathing. Current treatments are often unsatisfactory, usually with an implant for unilateral
cases that can be malpositioned, or by cutting out a portion of one or both vocal folds for bilateral cases, which
negatively impacts both voice and swallowing. Recent tissue engineering work in our lab and others has shown
that adult muscle progenitor (stem) cells (MPCs) can be isolated from a healthy skeletal muscle, cultured, and
implanted back into denervated laryngeal muscles. The MPCs become incorporated into the muscle
(engrafted) and increase its nerve recovery as well as its strength. In this proposal, the use of MPCs for VFP is
tested in an established canine model. In preliminary work, we found MPCs implanted into the vocal fold
muscles resulted in a significant increase in the strength of the laryngeal muscles as well as increased nerve
recovery. This project proposes further investigation of these exciting findings.
In Aim 1, we will repeat our preliminary experiment, and also alter the conditions to be more typical of
patients with VFP, with treatment delays of 3 months and 6 months from the time of RLN injury. We will also
vary the amount of cells implanted to find the optimum number. These results will provide data needed for a
possible clinical trial. To best simulate the size, volume and function of human laryngeal muscles, these
experiments will utilize canine larynges. In Aim 2, we will explore the finding that the implanted MPCs cause
an increase in innervation. How does implantation of muscle progenitor cells cause an increase in nerve
growth? We will use bulk RNAseq and mass spec imaging (MSI) to identify peptides or other potentially
neurotrophic molecules that are increased by implanting MPCs. Testing laryngeal muscles, with and without
implanted MPCs, at different time points will help characterize the cellular mechanisms. These findings could
lead to additional approaches to further maximize recovery of the injured RLN. These experiments will mainly
use a rat RLN model, with a few canines for validation in a larger model.

Public health relevance
PROJECT NARRATIVE Vocal fold paralysis (VFP) is a devastating condition that affects over 120,000 patients annually in the US; it commonly leaves patients with deficits in the voice production, swallowing, and breathing functions of the voicebox, and some patients even require a tracheotomy. Current treatments for VFP are suboptimal as they involve foreign body implants or are destructive of the vocal mechanism; the ideal treatment that restores vocal fold movement has not been found. This project tests a new approach using implanted adult muscle stem cells, which may be capable of restoring muscle activity to the paralyzed vocal fold muscles and allow for satisfactory voicing, swallowing and breathing without damaging the vocal folds.